UTMB CLINICAL AND TRANSLATIONAL SCIENCE AWARD: NASA BED REST STUDIES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This supplement will continue to support basic clinical and research services required to implement NASA's bed rest studies.